MECH OF CONDUCTION SLOWING DURING MYOCARDIAL STRETCH BY VENT VOL LOADING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Passive ventricular loading by volume inflation reversibly slows electrical conduction, but the mechanism behind this slowing remains unclear. We investigates the contributions of stretch-activated channels, altered membrane excitability, and changes in intercellular resistance or effective membrane capacitance during volume loading as the mechanism behind conduction slowing.